Commercialization Readiness of Immune Mediator Based Blood Tests that Inform Concurrent and Future Clinical Disease Activity in Systemic Lupus Erythematosus (SLE)

PROJECT SUMMARY/ABSTRACT
Systemic lupus erythematosus (SLE) is a multifaceted autoimmune disease characterized by immune
dysregulation, disabling symptoms and progressive organ damage. Recognition and early treatment to prevent
tissue and organ damage is challenging, as signs and symptoms of high disease activity and clinical disease
flare are captured after their occurrence. Despite clinical instruments of disease activity and improved
treatment regimens to temper chronic inflammation, SLE patients may experience an average of 1.8 disease
flares annually. Current treatment for ongoing heightened clinical disease activity and disease flares, which
must be done in reactive, rather than proactive, fashion, typically relies on rapidly acting, toxic agents such as
steroids. Earlier identification and proactive treatment of heightened clinical disease activity and imminent
disease flare might prevent significant organ damage and improve the quality of life for patients with SLE.
Our scientific premise is that alterations in SLE-associated immune pathways underlie ongoing clinical
disease activity and future disease flare. Traditional biomarkers incorporated in clinical disease activity
measures, including anti-dsDNA autoantibody and complement components, are not necessarily the earliest,
nor sufficient, biologic signals of worsening disease. Using a multi-analyte approach, we leveraged our recently
completed SBIR Phase I/II study to determine that lupus patients, prior to disease flare, have additional
immune dysregulation of multiple and varied immune pathways. This information was transformed into a Lupus
Flare Risk Index (L-FRI) that reflects the pre-flare immune status in lupus patients who go on to flare. Lupus
patients with ongoing heightened clinical disease activity are also at risk for permanent organ damage. We
therefore leveraged our initial studies to evaluate immune dysregulation in lupus patients with current low
disease activity vs. active clinical disease. Again, we observed alterations in multiple and varied immune
pathways, but in a different manner than what occurred prior to disease flare. This led us to design a Lupus
Disease Activity Index (L-DAI) that correlates well with clinical disease activity measures.
Our proposed late stage research in this SBIR SB1 CRP study is to leverage clinically well-characterized,
prospectively collected samples from ethnically diverse patient cohorts, including community settings, to
validate our algorithms. Aim 1 will focus on validation of our innovative L-FRI in SLE patients during pre-flare
vs. nonflare periods based on their future clinical disease activity. Aim 2 will focus on validation of the L-DAI in
SLE patients with concurrent low vs. active disease. In addition, we will leverage SBIR SB1 CRP technical
assistance funds to develop advanced clinical adoption (Aim 3) and reimbursement (Aim 4) strategies for our
L-FRI and L-DAI tests. The L-FRI and L-DAI tests are a game-changer in the lupus space by allowing
proactive disease management.

Public health relevance
PROJECT NARRATIVE Systemic lupus erythematosus (SLE) is a prototypic systemic autoimmune disease which causes significant morbidity and early mortality, especially in young minority women. SLE patients are at risk for ongoing heightened clinical disease activity and disease flares that often result in end-organ damage, and are only identified after clinical signs and symptoms have occurred. We propose to validate and prepare advanced marketing/clinical adoption and reimbursement strategies for a select panel of blood proteins that are known to activate or regulate the immune system and feed the results into innovative mathematical algorithms that assign a single, immune system-informed and clinically actionable disease activity or flare prediction scores to provide proactive information as to which SLE patients are likely to have heightened clinical disease activity or who are at risk of imminent disease flare (positive score) for early intervention, organ damage prevention, and reduced need for treatments that carry damaging side effects.